ORAL GANCICLOVIR AFTER TREATMENT WITH IV GANCICLOVIR FOR CMV GI DISEASE

The objective of this protocol is to study the tolerance and pharmacokinetics of oral ganciclovir in AIDS patients with CMV GI disease in remission.